Animal Models Module

PROJECT SUMMARY – ANIMAL MODELS
The animal model module provides facilities that are crucial to both understanding the
mechanisms behind disease and developing new treatments. The animal model module
provides state of the art equipment enabling the Wilmer Faculty to perform small animal
surgery, generate animal models, monitor disease progression and test potential
treatments. A new capability of the module has been added to support the generation of
genetically engineered Zebrafish models of ocular disease. The module's equipment
includes two operating suites with Zeiss ceiling hung microscopes as well as two ERG
machines, two Harvard micro-injectors, a Bioptogen SDOCT machine, an OptoMotry
optokinetics unit, and a Micron III imaging system. The animal operating rooms are
used extensively by Wilmer Faculty and have been helped to generate over 65
publications in the past five years. The animal model module is run by Drs. Gerard
Lutty and Malia Edwards who provide training on the use of all equipment. Dr. Edwards
routinely monitors the operating rooms and equipment are in good working order and
organizes servicing as needed. These facilities ensure that Wilmer Faculty continue to
be on the cutting edge of eye research.